Host genetic barriers to virus spillover

Project Summary

Viruses exploit cell surface receptors to gain access to the interior of host cells. These receptors are now
appreciated as major obstacles to virus spillover, a process by which animal viruses move from one host species
into another. In the many documented examples of spillover, viruses typically use the same entry receptor in the
old and new host, but need to acquire mutations to make them compatible with the specific ortholog of that
receptor found in the new host. Diverse viruses such as avian influenza viruses, rodent arenaviruses, MERS
coronavirus, and possibly SARS and Ebola viruses all overcame receptor barriers in humans as they transmitted
from their animal hosts. Here, we explore the following hypothesis of disease emergence: viruses can more
easily overcome receptor barriers when host individuals of specific receptor genotypes come into
contact. We use the simian immunodeficiency virus (SIV) reservoir in African primates as a model for this, and
investigate the role that the SIV/HIV receptors, CD4 and CCR5, play in limiting spillover of these viruses. Primate
lentiviruses (SIV/HIV) are an excellent model because the HIV/SIV receptors CD4 and CCR5 serve as significant
host barriers to the spillover of these viruses between primate species. We and others have shown that (1) CD4
and CCR5 vary from one species to the next in their ability to serve as receptors for HIV/SIV, and (2) different
individuals within primate populations have different virus susceptibilities because of receptor polymorphisms.
We leverage genetic data and biomaterials from approximately 1,300 primates representing 15 different species,
and a broad array of different HIV and SIV variants, to test the idea that certain individuals within populations
are better poised to transmit or receive infection during spillover scenarios. The main innovation of the proposal
is to define the role of host genetic variation in disease emergence, beyond a strict focus on the evolutionary
properties of viruses. The project will aid in our understanding of the evolutionary processes leading to the
emergence of new diseases. It is significant because the work here will be widely applicable to diverse viruses
beyond lentiviruses, and to host barriers beyond receptor blocks.

Public health relevance
Project Narrative Zika virus, dengue virus, and HIV all emerged as the result of virus spillover from primates to humans. Here, we will explore how certain host genotypes potentiate such spillover events, using simian immunodeficiency viruses (SIV and HIV) as our model. We also examine how these viruses evolve during successful spillover events.